Fluorescent Biosensors for measuring the signaling kinetics of GPCR ligands that activate G12/13 pathways.

Abstract
G-protein coupled receptors are outstanding drug targets. When the receptor is
activated, it signals through heterotrimeric G proteins, which in turn activate various
downstream effector proteins. The process of discovering new drugs that activate
particular G-protein coupled receptors depends on having functional assays that provide
insights into which compounds activate the receptor, which block it, and how long the
receptor is active. Today there are good assays for the receptors that activate the Gs, Gi,
and Gq proteins. There are remarkably few for the G12/13 family, which is particularly
important because this pathway is involved in cancer.
The receptors that signal through the G12/13 proteins are involved in cell adhesion, cell
invasion, or cell motility, the hallmarks of cancer behavior. Indeed the constitutively
active G12 protein can act as an oncogene. Given the biological importance of the
receptors that signal through the G12/13 pathway, reliable assays for the activation of
this pathway are needed. The first aim of this work is to determine the feasibility of
creating a live cell, fluorescent assay for G12/13 pathway activation that 1) can be used
on standard plate readers, 2) provides kinetic data about when the pathway is activated,
and for how long, 3) involves no additional enzyme substrates that can be depleted, and
4) can be used on a variety of cell types ranging from standard fibroblasts to cancer cell
lines.
Cross talk often occurs between different G-protein signaling pathways. Some receptors
activate multiple different G proteins, and it is often the case that a receptor will activate
both the Gq and G12/13 pathways. The second goal of this project is to determine the
feasibility of creating CRISPR/Cas9 tools with the specific guide RNAs to selectively
knock out different G proteins. These tools would be capable of removing the function
of a G protein in a matter of days such that receptor driven signaling could be compared
in parallel wells of identical cells missing different signaling pathways. The final goal of
the project is to combine the RhoA sensor, CRISPR tools, and biosensors for DAG, Ca2+,
cAMP, β-arrestin to completely characterize the PAR1 receptor and potential agonist
bias at this receptor in breast cancer cell lines.

Public health relevance
Narrative Many of the drugs in use today target G-protein coupled receptors, and better tools to study the activation of these receptors are the key to developing better therapeutic drugs. Receptors that signal through the G12/13 pathway are important drug targets in cancer. These receptors are understudied because the assays to detect the activation of the G12/13 pathway are quite limited. The goal of this Phase I proposal is to determine the feasibility of creating live cell fluorescent assays for G12/13 signaling that are robust enough for standard fluorescence plate readers and enable easy evaluation of drug candidates based on their signaling profiles.